Sensory contributions to third visual pathway dysfunction in schizophrenia: correlation and causation

ABSTRACT
Schizophrenia (Sz) is associated with deficits in social cognitive function that represent a core feature of the
disorder. At present, the neural mechanisms underlying these impairments remain relatively unknown and no
specific treatments are available. A recent advance in the conceptualization of human social cognition is the
description of a primate specific Third Visual Pathway (TVP) that is specialized for processing of social
information. This pathway preferentially utilizes motion input relayed through the primary visual (V1) and motion-
sensitive middle temporal cortex (MT+) into the posterior superior temporal cortex (pSTS), an area known to
respond to a variety of dynamic social cues including faces and bodies. This project builds from three convergent
recent projects within our group. First, we have developed a multimodal ERP/fMRI approach sensitive to TVP
dysfunction in Sz and have demonstrated significant interrelated impairments in both MT+ and pSTS activation
which, in turn, correlate with impaired face emotion recognition (FER). Second, using naturalistic viewing fMRI
(NV-fMRI) we have demonstrated that individuals with Sz show reduced sensitivity to face motion within a social
scene and altered patterns of connectivity within TVP structures, including the pulvinar nucleus of the thalamus.
Most recently, using co-activation pattern (CAP) state analysis, we have demonstrated decreased occupancy in
Sz of states that are associated with increased activity in visual, face processing and TVP regions and increased
occupancy of CAP states associated with visual system deactivation. Finally, we have developed expertise in
simultaneous application of personalized high-definition transcranial direct current stimulation (pHD-tDCS)
concurrent with both fMRI and EEG data acquisition for reversal of visual sensory-level dysfunction in Sz. In
preliminary within-subject data, we have observed that pHD-tDCS over MT+ significantly enhances not only MT+
activation to random-dot kinematogram (RDK) stimuli, but also pSTS activation to dynamic face emotion stimuli.
These activation changes are associated with correlated improvements in motion sensitivity and FER. Here, we
will combine these three currently separate lines of investigation – sensory-level visual assessment, NV-fMRI,
and pHD-tDCS - to 1) evaluate mechanisms underlying TVP and social cognitive dysfunction in Sz, and 2)
develop potential approaches for future clinical TVP-targeted therapy. Participants will include 120 Sz and 30
healthy control volunteers, who will participate in baseline ERP and fMRI assessments of TVP function along
with clinical measures of social function and global outcome. Directional analyses will investigate the relationship
between baseline sensory-level visual dysfunction, higher-tier TVP dysfunction, social cognition and global
outcome. Sz participants will additionally be randomized to active (cathodal) vs. sham MT+-targeted pHD-tDCS.
Convergent ERP and fMRI outcome measures will assess potential causality in the relationships between
improved sensory-level motion processing and improved higher-tier TVP function. If successful, the project will
provide crucial pilot data for longer term pHD-tDCS-enhanced social cognitive remediation approaches.

Public health relevance
Narrative Schizophrenia is a severe neuropsychiatric disorder and a leading cause of long-term disability that is driven especially by impairments in social cognition. The neural mechanisms underlying these impairments remain relatively unknown and no specific treatments are available. This study uses multimodal imaging and non- invasive brain stimulation to investigate neural mechanisms linking deficits in early visual processing in schizophrenia to higher order social cognitive dysfunction and impaired functional outcome. A long-term goal of this project is development of improved paradigms for enhancement of social cognitive remediation in Sz.